Project 2: Regulation of Pre-mRNA Splicing in Tumorigenesis

PROJECT SUMMARY - PROJECT 2
The central goal of Project 2 is to understand the various roles of alternative splicing in cancer, and to exploit
cancer-specific features of this process to develop targeted-therapeutic approaches. Cancer cells display
extensive qualitative and quantitative dysregulation of splicing, and a subset of the numerous isoforms that are
inappropriately expressed contribute to tumorigenesis or altered cell metabolism. The mechanisms and
pathways through which the splicing-factor oncoproteins SRSF2 and SRSF1 transform cells will continue to be
investigated. Cell-culture models, as well as orthotopic and genetic mouse models will be used to study
tumorigenesis promoted by these splicing factors upon mutation or overexpression in different cancer contexts,
with an emphasis on recurrent mutations in myeloid dysplasias. High-throughput RNA-sequencing and
computational analysis will be employed to identify and compare the splicing targets of these SR proteins in
different cancer contexts, and selected targets will be characterized and manipulated to evaluate their
contributions to tumorigenesis and potential as therapeutic targets or biomarkers. One key event, alternative
splicing of pyruvate kinase pre-mRNA, which controls the distinctive glycolytic metabolism of cancer cells, will
be thoroughly investigated as a potential therapeutic target, by specifically manipulating this process in vivo,
using antisense technology and mouse models of glioma and hepatocellular carcinoma.

Public health relevance
PROJECT NARRATIVE - PROJECT 2 Alternative splicing is a fundamental step in the normal function of genes. In cancer cells, this process is altered in ways that can contribute to tumor growth. By studying the roles of alternative splicing in cancer, unique vulnerabilities of cancer cells can be uncovered, which can then be investigated as therapeutic targets.